Real-time and randomized tests of social media and mental health interplay in early adolescence

PROJECT SUMMARY
Adolescent mental health has worsened over the last decade and increased time spent on social media is often
cited as a contributing factor. Parents, policymakers, and educators are being told to curb social media use.
However, whether restricting or changing exposure to social media use will impact mental health is largely
unknown. This research builds on our previous prospective, longitudinal, and intensive study of a population
representative sample of young adolescents. Mental health symptoms and social media use will be captured at
the daily, weekly, and yearly levels via ecological momentary assessment (EMA), passive sensing, wearable
technologies, and a new youth co-created open application program interface (API) toolkit. Social media
engagement will be captured via real time assessments alongside the extraction of social media histories via a
youth co-created API toolkit. A large representative sample of 2500 11- to 15-year-olds will be followed over four
years, with a subset of 750 adolescents followed intensively via EMA to experimentally test whether social media
restriction versus scaffolding (a) modifies social media engagement and (b) impacts mental health symptoms in
the moment, across days, and over years. Early adolescence is a key period for testing bi-directional associations
between social media use and mental health given the onset of common and costly mental disorders like anxiety
and depression, evidence of heightened response to interventions, and the fact that young people begin to
navigate online spaces independently at this time. The study is positioned to impact on science, practice, and
policy by (1) advancing discovery related to differential bi-directional influences between social media and mental
health, (2) testing whether experimental modifications to social media-engagement impact same day and future
mental health symptoms, (3) identifying subgroups of adolescents for which bi-directional linkages and/or
intervention impacts may be amplified, and (4) creating a novel resource for the field that will allow adolescents
to access, control, and share their digital trace data to advance research, interventions, and policy.

Public health relevance
PROJECT NARRATIVE Adolescent mental health has worsened in recent years and increased time spent on social media is cited as a contributing factor. This study provides a prospective, high-resolution, multi-informant, and experimental test of bi-directional influences between young adolescents’ social media use and mental health symptoms. In doing so, the research is positioned to advance science, support adolescents, and respond to calls from policymakers, researchers, educators, and parents to better understand how social media engagement can impact adolescents’ mental health.